TASK ORDER 06 (75N95021F00001) FOR IDIQ HHSN271201800024I WITH EUROFINS PANLABS DISCOVERY SERVICES

The Division of Therapeutics and Medical Consequences (DTMC) supports a contract-based research program (the Addiction Treatment Discovery Program) that acts to test potential medications for safety and efficacy in developing them as drugs to be used in the treatment/prevention of drug abuse.